Protein RNA Rearrangements in the Spliceosome

ABSTRACT
Excision of introns from precursor messenger RNA by the spliceosome is a critical step in almost all
human gene expression. This process is highly regulated, integrally linked with the transcription of genes and
other processing events, such as polyadenylation and nucleotide modification.
The mechanism by which the spliceosome recognizes the exact sites for the chemical events and how
the reactions are catalyzed are not well understood. The long-term goals of this project are to understand
interactions and rearrangements between spliceosome components and the RNA ligands that are substrates
for the catalytic reactions. Ample evidence argues for multiple rearrangements of factors and multiple
recognition events at the branch site. Investigation of these events — which are not understood
mechanistically — will elucidate interactions and rearrangements among core components and may serve as a
paradigm for rearrangements in the spliceosome and in other RNP machines. This proposal focuses on
mechanisms by which spliceosomal dynamics impact splicing fidelity.
The Aims of this project focus on two newly-discovered aspects of the spliceosome and snRNAs:
(1) We will investigate the role of inositol hexakisphosphate (IP6) in spliceosome function. This small molecule
was recently identified unexpectedly by cryo-EM as part of splicing complexes. No biochemistry or genetics
has so far explored its importance. We use mutants in the IP6 biosynthetic pathway to explore its contribution
to splicing and whether inositol polyphosphate (IPP) isoform levels may influence splice events. (2) One hole
in our current understanding of RNA biology is the role of snRNA mutations in disease. Two mutations were
recently described in the 5'-end of U1 snRNA, associated with glioblastoma (GBM) and other cancers. We will
use our in silico snRNA genome to interrogate TCGA whole genome datasets (WGS) and investigate, in
particular, U2 snRNA mutations that we find highly enriched in bladder cancer and bladder cancer organoid
lines.

Public health relevance
PROJECT NARRATIVE / PUBLIC HEALTH RELEVANCE STATEMENT Excision of introns from pre-mRNA is critical in the pathway of gene expression. This excision occurs within spliceosomes and requires precise recognition – during both spliceosome assembly and splicing catalysis – of three sites (two splice sites and a branch site) to appropriately join exonic coding sequences. Mutations in components of the U2 snRNP are implicated in myelodysplastic syndrome (MDS) and other cancers, and mutations that alter snRNP levels underlie spinal muscular atrophy (SMA). The roles of small molecule IP6 and mutations in U2 snRNA, identified here, have not previously been investigated. Our studies will provide a better understanding of U2 snRNPs, their interactions with the RNA ligands that are substrates for catalysis, and how disease-related mutations alter this process.